KINETICS STUDIES OF INDIUM-LABELED LEUKOCYTES

The kinetic patterns of fresh, frozen-thawed or cultured human leukocytes are studied by tagging the cells ex vivo with 111Indium, a radiosotopic label, and measuring their distribution throughout the body by means of gamma camera imaging and gamma counting of blood samples.